The Familial Alzheimer Sequencing (FASe) Project

Abstract
Family-based approaches led to the identification of disease-causing Alzheimer’s Disease (AD) variants in the
genes encoding amyloid-beta precursor protein (APP), presenilin 1 (PSEN1) and presenilin 2 (PSEN2).
Subsequently, the identification of these genes led to the Aβ-cascade hypothesis and recently to the
development of drugs that target that pathway. In this proposal, we will identify rare risk and protective alleles.
In a recent study, we identified a rare coding variant in TREM2 with large effect size for risk for AD, confirming
that rare coding variants play a role in the etiology of AD. We will use sequence data from families densely
affected by AD, because we hypothesize that these families are enriched for genetic risk factors. We already
have access to sequence data from 695 families (2,462 individuals), that combined with the ADSP data will
lead to a very large family-based dataset: more than 805 families and 4,512 participants. Our preliminary
results support the flexibility of this approach and strongly suggest that protective and risk variants with large
effect size will be found. The identification of those variants and genes will lead to a better understanding of the
biology of the disease.

Public health relevance
NARRATIVE Aging populations worldwide, particularly in developed countries, face an increasing burden of neurodegenerative diseases, especially Alzheimer's disease (AD). Recent studies indicate that there are rare variants with large effect size for risk for Alzheimer's disease, that are not identified by genome-wide association analysis. Family-bases studies have been instrumental to identify Mendelian and risk genes for AD and other complex traits. In this study, we propose to analyze a very large family-based dataset to identify both risk and protective variants and genes.